Manganese exposure and genetic diversity in risk mechanisms for neurodevelopmental disorders

ABSTRACT
The broad, long-term objectives of the grant are to increase our understanding of the mechanisms underlying
the gene x environment interactions that link developmental manganese (Mn) exposure, dopamine (DA)
dysregulation and increased frequency of ADHD diagnoses. Through the use of both sexes and varied genetic
backgrounds in our testing models (mice and human iPSC lines) we use a rigorous approach to deepen our
understanding of the role of genetics on the strength of the mechanisms under investigation. Strong
epidemiological and correlation evidence points to a relationship between overexposure to metals, including
Mn, and development of childhood and adolescent neuropsychological disorders. We will use oral exposures
to mimic exposure to Mn through poorly filtered water such as that obtained from wells, at levels relevant to
known human exposures in N. America. We will support our behavioral studies with comprehensive analyses
of dopaminergic (DAergic) function including post-mortem analyses of brain tissues, electrophysiology
approaches in live brain slices and in vitro study of human induced pluripotent stem cell (hiPSC)-derived DA
neurons. Our first Specific Aim is to Determine the role of sex and genetic background on Mn exposure-
induced behavioral change and DAergic transport deficits. Three background strains have been selected for
their baseline differences in DAergic function, Mn metabolism and locomotor activity. Mice will be exposed to
control, moderate or high Mn through water from weaning to assess the impact of sub-toxic (i.e. no expected
cell death) Mn levels in brain during development. We will use a range of behavioral outcomes that are
representative of changes observed in ADHD as well as variation observed in the general public. We will study
DA metabolism and release/reuptake kinetics through neurochemistry, post translational protein modifications,
RNA and electrophysiology approaches. In Specific Aim 2 we will Test whether Mn modifies pharmacological
modulation of DA transport in vivo. We will use genetic approaches to generate mild disturbances in the
DAergic system from birth that cause only modestly altered phenotypes (behavioral and cellular). We will then
test whether Mn exposure is sufficient to drive these mild presentations towards full expression of abnormal
phenotypes mimicking a classic gene x environmental exposure model of development of Intellectual and
Developmental Disabilities. We will further test the potential for Mn to impact efficacy of common treatments for
ADHD. Finally, in Specific Aim 3 we will determine whether Mn has an ADHD-related differential impact on DA
functional characteristics of human induced pluripotent stem cell (hiPSC)-derived DAergic neurons. We will use
cell lines derived from males and females under baseline conditions, and following genetic mutation of the DA
transporter, or exposure to chemical ADHD risk factors. We will assess changes in neurochemistry and post-
translational modifications to test the potential translational relevance of Aims 1 and 2. We will use single-cell
genetic pathway analysis to test hypotheses about which pathways are disrupted by Mn.

Public health relevance
NARRATIVE There is strong correlational and epidemiological data to support a link between exposure to high levels of manganese, dopamine dysregulation, and development of Attention Deficit and Hyperactivity Disorder (ADHD) and other neurodevelopmental disorders. Current research and treatments are limited by lack of reproducibility in animal and cellular studies limiting translational relevance to humans. Rigorous testing of effects of chronic sub-toxic exposures across sexes, genetic background, and disease-associated genotypes in animal and human-derived cell models will clarify the role of biological variability in the response to environmental exposures and individual differences in response to pharmacological interventions.